Informing mechanistic rules of agent-based models with single-cell multi-omics

PROJECT SUMMARY
Cancer is driven by interactions between diverse cell types and their tissue microenvironment. Emerging single-
cell and spatial transcriptomic systems are mapping cancer tissues, in the process capturing the diversity of cell
types and states and exposing the importance of spatial cell interactions in determining therapeutic response in
individual patients. Multi-omics software developed in ITCR—including CoGAPS, projectR, SpaceMarkers, and
Domino developed by our group—can analyze single-cell and spatial multi-omics data to infer cell types and
phenotypes in the tumor microenvironment, identify which cells interact, and discover how cell-cell interactions
drive molecular changes. However, these analyses yield static snapshots that cannot capture the dynamics of
cancer ecosystems. Mathematical modeling can “fill in the gaps” between these snapshots, allowing teams to
form hypotheses on how and why cells interact, “encode” their hypotheses as simulation rules, and perform
“virtual experiments.” However, simulation rules and their parameters are difficult to match to genomic data. This
proposal bridges the gap between bioinformatics and mathematical biology by merging our bioinformatics soft-
ware for single-cell and spatial multi-omics data with PhysiCell, an agent-based modeling framework developed
by our group to simulate the movement and interaction of many individual cell agents in virtual tissue environ-
ments. The “glue” between these packages is a novel cell behavior grammar that “encodes” cell rules learned
from high-throughput data as intuitive, interpretable hypothesis statements that can be automatically transformed
into simulation code. In this proposal, we refine the cell behavior grammar while analyzing previously published
cancer data to create digital “templates” for key cell types in cancer ecosystems, refine PhysiCell to import the
templates, and create PhysiCell Cloud: a free, “zero-install” cloud resource to build, execute, and visualize can-
cer models without writing computer code. We refine CoGAPS, SpaceMarkers, projectR, and Domino to learn
cell behavior rules from spatial transcriptomics data and format them with the grammar, and extend PhysiCell to
read cell types, positions, and rules stored in standard single-cell, spatial, and multi-omics classes. We develop
sophisticated pipelines for PhysiCell models that can quantify model uncertainty, automatically fit models to tran-
scriptomics data, and validate models on real world tumor datasets. We extend PhysiCell Cloud to a full-fledged
science gateway that includes secure and searchable user storage, data structures and code (APIs) to connect
PhysiCell Cloud to Python, R, and Bioconductor pipelines in ITCR, and a cost-free high-performance computing
backend to seamlessly run large-scale model exploration and uncertainty quantification pipelines. Educational
expertise and community feedback—including from an advisory board, annual training workshops, and daily
classroom use—will drive usability refinements. Altogether, this approach will bridge bioinformatics and mathe-
matical modeling to provide a comprehensive platform for patient-specific mechanistic tumor modeling, to enable
future computationally-drien experimental design, virtual clinical trials, and digital twins research.
‘

Public health relevance
PROJECT NARRATIVE Sophisticated single-cell and spatial multi-omics data provide unprecedented characterization of the regulatory programs of cellular phenotypes in tumors and their microenvironments, but they do not capture the dynamics of cell interactions that drive cancer progression. Agent-based simulation models (ABMs) allow scientists to test hypotheses as model rules, but it is challenging to determine model rules from imaging data. This project will merge state-of-the-art bioinformatics tools for spatial multi-omics data with web-hosted ABM software to give scientists new, biologically interpretable tools to learn, refine, and manipulate the rules of cancer ecosystems, paving the way for future cancer patient digital twins and next-generation predictive medicine. ‘